Role of Astrocytic miR-20a-3p as a Potential Therapeutic for Ischemic Stroke

Project Summary
The goal of this project is to test a therapeutic compound that has the potential to improve stroke outcomes in
older females. It is critical to focus on this demographic because studies show that after menopause, women
have greater risk and severity of ischemic stroke. Previous studies from the sponsor's lab have shown that
reproductively senescent (acyclic) (RS) female rats have larger infarct and worse sensorimotor impairments
than younger females. Moreover, estrogen replacement to RS females exacerbates stroke impairment. Thus
this animal model replicates key features of stroke-related consequences seen in the human population,
resulting in a model with translational potential, in which neurotherapeutic compounds can be tested.
Prior research from the sponsor's lab has shown that astrocytes from reproductively senescent (RS) female rats
exhibit age-related changes that contribute to poorer recovery after stroke. This includes a reduced capacity for
glutamate clearance, decreased secretion of trophic factors, and increased release of inflammatory cytokines,
compared to younger females. Furthermore, these aging astrocytes also display reduced histone methylation of
the H3K4 chromatin region, resulting in less transcription of several genes including the microRNA mir-17-92
cluster. MicroRNAs have recently gained popularity as potential therapeutics for a variety of conditions,
including ischemic stroke.
Preliminary data for this proposal shows that miR-20a-3p, a member of the mir-17-92 cluster is dramatically
down regulated in astrocytes of middle-aged females. Furthermore, iv injection of miR-20a-3p mimics four
hours after middle cerebral artery occlusion (MCAo) decreased infarct volume and attenuated sensorimotor
impairment in middle-aged females, suggesting that the miR-20a-3p could be mechanistically linked to stroke
outcomes. This raises the intriguing possibility that in younger females, endogenous astrocyte-derived miR-
20a-3p may be `distributed' to other cells to improve stroke outcomes. This hypothesis will be tested in the
following aims: Aim 1 will determine whether miR-20a-3p alters the composition of astrocytice extracellular
vesicles (EVs) and that miR-20a-3p modified EVs will confer neuroprotection. Astrocytes have been shown to
release neuroprotective factors, organelles and RNA translational machinery through EVs after stroke. In silico
analysis predicts that miR-20a-3p may regulate inflammatory mediators and mitochondrial genes. Thus, miR-
20a-3p could drastically change the composition of the EVs. In aim 2, replication-deficient adenovirus
constructs will be used to increase miR-20a-3p levels only in astrocytes and determine whether this
recapitulates the neuroprotective effect of iv miR-20a-3p. Using clinically relevant stroke models, a battery of
behavioral assays, and modern gene transfer techniques, this proposal will critically examine whether
modification of the aging astrocyte will promote neuroprotection.

Public health relevance
Project Narrative: This proposal seeks to analyze astrocyte-specific mechanisms of neuroprotection of a potential therapeutic for ischemic stroke, miR-20a-3p. Astrocytes exhibit sex-specific and age-related epigenetic changes including dramatic down-regulation of miR-20a-3p, that may predispose older females to worse outcomes after ischemic stroke. Preliminary data has shown this miRNA to be neuroprotective when delivered iv after stroke, and we propose that the neuroprotective mechanism of miR-20a-3p relies on altering the transfer of genes and proteins to other brain cells.